IGF::OT::IGF : Analytical Chemistry and Stability Testing of Treatment Drugs for Substance Use Disorders. August 4, 2014 - August 3, 2019. N01DA-14-8918.

Develop or improve test methods for drug substances and drug products provided by the Government to ensure the purity, identify and strength, and to characterize them physically and chemically and to validate analytical methods developed for drug substances and finished dosage forms to include documentation, as needed, of method specificity, linearity, accuracy, precision, detection limit, quantitation limit, recovery, ruggedness, and sample stability in a format acceptable to the FDA.